Making Mindfulness-Based Cognitive Therapy accessible for underserved pregnant people: Developing Center M for commercialization

PROJECT SUMMARY/ABSTRACT
A highly effective intervention to prevent perinatal depression, mindfulness-based cognitive therapy for perinatal
depression (MBCT), exists; however, critical implementation gaps prevent its wide use. And though universally
recommended, not all prenatal care clinics effectively screen for perinatal depression (PD). Overcoming current
implementation gaps is imperative to address the public health crisis of high US maternal morbidity and mortality.
With prevalence ranges from 11 – 20% of the 3.8 million people who birth every year, PD is one of the most
common childbearing morbidities. And deaths of despair (suicide; overdose) is the leading cause of maternal
death. Though rates of perinatal depression are higher, mental health care is less available among underserved
women [Black and/or Indigenous and/or Medicaid users]. Recent federally funded maternal mortality review
results indicate that 100% of perinatal depression related deaths were preventable. Pregnancy is the optimal
time to realize prevention: pregnancy timed intervention is both critical (early intervention improves outcomes)
and feasible (prenatal care standardly includes 10-12 clinical visits, and pregnant people are highly motivated to
receive prenatal care). CenterMom, Inc. is advancing solutions to these problems via the Center M product: an
adaptation of MBCT designed to improve intervention delivery in our target population. Center M pilot work
indicates the need for smartphone app delivery of PD screening and home practice materials to succeed in this
effort. The purpose of the proposed Phase I STTR is to prototype a smartphone app that can effectively deliver
appealing PD screening and Center M home practice materials and test the Center M product inclusive of this
app. The overarching hypothesis to this line of inquiry is that pregnant people randomized to the app inclusive
Center M intervention, vs. treatment as usual (TAU), will receive significantly better PD screening, will have lower
rates of PD at 6 weeks postpartum, and will be highly satisfied with their antenatal preventive mental health care.
The proposed work is a critical step to achieving MBCT-PD portability within standard prenatal care health
systems and acceptability among underserved pregnant people. Our team, including experts in biomedical
commercialization, psychology, mindfulness, community-partnerships, Black maternal health, and prenatal care
health systems will critically inform two specific aims: Specific Aim 1: Build a Center M app prototype consistent
with underserved, pregnant end user needs. We will conduct 4 focus groups consisting of 5 pregnant end users
per group (N=20) focusing on identifying user needs. Using this data and preliminary data, we will complete the
app prototype. Then we will conduct app prototype usability testing with 20 additional pregnant people (n = 20).
Specific Aim 2: Test efficacy and effectiveness of Center M vs. TAU. We will conduct a pilot randomized trial
with 90 pregnant people to test Center M vs. TAU. We will track rates of PD screening and depression scores
through 6-weeks postpartum and PD care patient satisfaction. Study findings will inform STTR Phase II.

Public health relevance
PROJECT NARRATIVE High rates of depression among pregnant and postpartum people have been recognized as a significant public health problem, particularly among those who are Medicaid-supported and/or Black and/or Indigenous. CenterMom, Inc, has adapted an intervention that is effective in preventing perinatal depression to improve delivery and appeal among Medicaid-supported and/or Black and/or Indigenous pregnant people; end users signal that our product, Center M, will be more satisfactory when perinatal depression screening and intervention home practice delivery is accessible via a smartphone app, thus the proposed research seeks to prototype and test the Center M smartphone app. This work has significant potential to increase the availability of effective perinatal depression prevention strategies among underserved populations and thereby address the NIH missions of supporting child health and well-being, increasing health equity, and preventing maternal morbidity and mortality.